Endothelial Cell Health Across the Spectrum of Cardiometabolic Disease

Project Summary/Abstract
The escalating prevalence of cardiometabolic risk factors including obesity and type 2 diabetes mellitus
(T2DM) presents a critical cardiovascular challenge. Individuals with cardiometabolic disease harbor greater
risk of cardiovascular disease (CVD) including accelerated vascular aging and premature atherosclerotic
disease. Importantly, alterations in endothelial function predate the development of clinical CVD, making the
vascular endothelium an important potential target for cardioprotection. Experimental studies and our prior
work link altered metabolism to organelle stress including mitochondrial dysfunction and ER stress. In this
proposal, we hypothesize that organelle stress induced by cardiometabolic traits drives vascular dysfunction
and promotes CVD. We will leverage the unique resources of the planned Framingham Heart Study fourth
examination cycle to prospectively collect fresh human endothelial cells (EC) from 2000 individuals. In Aim 1,
we will investigate the association of T2DM and cardiometabolic traits with EC phenotype including organelle
stress and nitric oxide signaling in a nested case-control sample of 450 individuals. In Aim 2, we will measure
EC gene expression levels using RNA sequencing in 900 participants to identify and prioritize EC
transcriptional programs linked to EC health phenotypes, cardiometabolic traits, and systemic metabolism. This
proposal leverages a unique and highly experienced multidisciplinary team of investigators with expertise in
obesity-related cardiovascular disease, endothelial biology, population science, translational patient-oriented
research, multi-omics and bioinformatics. The proposed work will dwarf past efforts at defining endothelial
health across disease states and will combine new deep phenotyping of EC conducted at scale in a
community-based cohort with existing rigorous measures of cardiovascular health including metabolite profiles
and genomic markers. These studies have the potential to provide important insights into mechanisms driving
endothelial dysfunction and develop an unprecedented resource that will benefit vascular biology research.

Public health relevance
Project Narrative (Public Health Relevance) Given the rising burden of obesity, diabetes, and heart disease in the community, new approaches are needed to maintain blood vessel health from the impact of cardiometabolic traits. The proposed research investigates the impact of cardiometabolic diseases on health of the blood vessel lining cells, endothelial cells, by measuring stress markers and gene expression pathways. Our results will clarify how cardiometabolic diseases result in different patterns of endothelial cell gene expression and may identify novel molecular underpinnings of cardiovascular risk that will have important preventive and therapeutic implications.